DEPRESSION AND TRIAL OF VARICELLA VACCINE IN THE ELDERLY

Determine whether major depressive disorder is associated with declines in varicella zoster vaccine specific immunity in adults 60 years of age and older. Determine whether major depressive disorder alters vaccine-stimulated varicella zoster virus sepcific immunity.